Project 2- Liquid Biopsies for Melanoma that Metastasizes to Inaccessible Sites

PROJECT 2: PROJECT SUMMARY
With the rise in incidence of metastatic melanoma and prolonged survival of patients with this disease, an ever
increasing number of patients are living with metastatic melanoma and requiring therapy. Not all patients respond
to PD-1 inhibitors, and there is therefore an urgent need for means to predict response to this class of agents,
to monitor patients for response, and to understand mechanisms of sensitivity and resistance to these drugs that
might be harnessed for designing effective combination regimens. Although tumor cell properties, such as PD-
L1 expression, are somewhat associated with response, mounting evidence generated suggests that properties
and quantity of tumor infiltrating inflammatory cells might be more informative in terms of predicting and
monitoring response and can enable us to determine approaches to overcome resistance. However, melanomas
often metastasize to areas that are difficult to biopsy, such as the brain, spleen, small bowel and bone, and we
therefore propose approaches to studying properties of tumor infiltrating lymphocytes (TIL) by isolating and
profiling T cells that originated in the tumor but can be identified in the circulation. In previous studies we
demonstrated that these circulating T cells, which express both PD-1 and TIM-3, are specific to the tumor
microenvironment, and are not found in the circulation of healthy individuals or patients with autoimmune
disease. We propose to conduct single cell analysis of these TIM3+PD-1+ circulating CD4 and CD8 cells that
have been in tumor tissue using state-of-the-art technologies. We have assembled a team of interdisciplinary
researchers with the goal of developing liquid biopsy methods to determine mechanisms of resistance to immune
checkpoint inhibitors. We will start by conducting single cell CyTOF and functional cytokine analysis of CD4 and
CD8 cells from the circulation and tumor tissue to determine similarities and differences at the molecular level.
We will then barcode TIM3+PD-1+ cells using TcR chain sequences to identify circulating TIL by the presence of
TcR sequences that are identical to TIL isolated from tumors representing sister clones. Using single cell RNA-
seq, we will therefore be able to assess TIL function by studying function in this population of circulating TIL.
This will be done on prospectively collected matched samples from melanoma patients undergoing resection of
metastases, including brain metastases, biopsies from other sites and blood samples. Our liquid biopsy
technique then be studied on blood samples from patients treated with PD-1 inhibitors before and on therapy,
with complete clinical annotation including response to therapy. If successful, our liquid biopsy approach can be
applied to other treatment settings and other tumor types, and thus has the potential to significantly impact patient
care by enabling improved patient selection and avoiding the morbidity and expense associated with repeat
tumor biopsies. Moreover, the single cell analysis will enable us to better understand mechanisms of resistance,
which in turn can facilitate drug development for patients with tumors resistant to PD-1 inhibitors.

Public health relevance
PROJECT 2: PROJECT NARRATIVE The number of patients with metastatic melanoma and other tumor types receiving immune therapy is consistently growing, yet we still lack reliable means to predict who will respond and why some patients respond while others do not. One of the limitations to developing tests to predict and understand resistance is the need to conduct sequential biopsies on patients, which is often difficult or impossible and can be costly. Here we propose to develop novel methods to sample immune cells in the blood by isolating and studying cells that were previously in the tumor bed, to enable us to use a personalized medicine approach for patients receiving immune therapy.